The role and fate of Mtb storage lipids LCTAG and MWE

SUMMARY Tuberculosis is one of the leading causes of death due to infectious disease despite the availability of anti- tubercular drugs. The majority of M. tuberculosis (Mtb) infections result in latent TB where bacteria have altered metabolism and exhibit phenotypic drug tolerance. The biological pathways used to maintain metabolic homeostasis and then fuel resuscitation and replication are poorly understood. A crucial component of dormancy or quiescence is the storage of carbon and energy sources in cell wall lipids that can be recycled upon resuscitation. Mtb generates the “storage lipids” triacylglycerol (TAG) and wax esters (WE) in late stationary phase and in response to stresses commonly associated with dormancy. During the transition to active replication, it is believed that these lipids are mobilized and employed as a metabolic resource. However, this has not been experimentally demonstrated. We recently described the Very Long- Chain triacylglycerol (LCTAG) and mycolate wax ester (MWE) of Mtb. These lipids are exported from the cytoplasm to the mycobacterial outer membrane or capsule by the MmpL11 transporter. The fates of LCTAG and MWE once they are extracellular are not known. However, correct localization of LCTAG and MWE is important for Mtb virulence and physiology since 1) MmpL11 is required for virulence and 2) the Mtb mmpL11 mutant has reduced resuscitation from an in vitro non-replicating persistence model. As storage lipids, surface- localized LCTAG and MWE may be utilized as a shared resource to maintain viability and resuscitate from non-replicating persistence. Based on our data, we hypothesize that Mtb hydrolyzes, imports and utilizes exported storage lipids to promote resuscitation from hypoxic and nutrient-restricted environments. We propose to test this hypothesis by 1) Determining how LCTAG and MWE contribute to Mtb resuscitation from non-replicating persistence, and 2) Define proteins involved in the LCTAG and MWE biosynthesis and recycling pathway. This exploratory study combines unbiased approaches with genetic and biochemical analyses to investigate the important biological process of Mtb cell envelope remodeling in metabolism.

Public health relevance
PROJECT NARRATIVE We recently described the Long-Chain triacylglycerol (LC-TAG) and mycolate wax ester (MWE) of Mycobacterium tuberculosis (Mtb) that are exported from the cytoplasm to the mycobacterial outer membrane or capsule by the MmpL11 transporter. TAGs and wax esters have been described as “storage lipids”, but the fates of LCTAG and MWE once they are extracellular are not known. This proposal will test the hypothesis that Mtb utilizes exported storage lipids to promote resuscitation from hypoxic and nutrient-restricted environments.